Impact of harm reduction care in HIV clinical settings on stigma and health outcomes for PLWH who use drugs

People living with HIV (PLWH) who use drugs exhibit low rates of retention in care and poor clinical outcomes. HIV and hepatitis C (HCV) often co-occur due to shared routes of transmission including injection drug use, which is also associated with risk for opioid overdose. PLWH who use drugs experience anticipated and enacted stigma in healthcare settings, which contribute to poor clinical outcomes. Harm reduction (HR) is an approach that aims to reduce the negative effects of risky health behaviors without necessarily eliminating them completely and is an effective way of engaging people who use drugs into care. Though often thought of as strategies like syringe services, harm reduction is also a relational approach to care that focuses on non-punitive, autonomy-building relationships between patients and providers. This R01 will explore the degree to which HR strategies and relational HR buffer stigma experienced in HIV primary care settings by PLWH who use drugs, and improve the quality of patient-provider relationships as well as clinical outcomes. The study will explore healthcare providers' attitudes towards working with PLWH who use drugs and the ways these relate to their acceptance and practice of HR care. This will be accomplished via web- based surveys (n=125) and qualitative interviews (n=20) with healthcare providers in Pittsburgh, PA and Birmingham, AL. These methods will utilize a multi-level lens, engaging multiple provider types, such as social workers, nurses, and physicians working in HIV primary care teams. The study will also assess the degree to which patients' perceptions of their HIV providers' HR care are associated with anticipated and enacted stigma in HIV primary care settings and with clinical outcomes. Data will be collected by surveying PLWH who use drugs (n=500) to explore if structural and relational HR mitigate stigma, improve the patient-provider relationship, and ultimately improve clinical outcomes as measured via electronic health records data including HIV viral load, retention in HIV primary care, HCV sustained virologic response, medication adherence, and retention in care for Medications for Opioid Use Disorder and/or in behavioral health treatment for substance use disorder. Study methods will include an evaluation of the psychometric properties of the Patient Assessment of Providers Harm Reduction Scale (PAPHRS), a novel scale to measure relational HR. Finally, the study will apply human-centered design approaches to engage stakeholders in reviewing findings from providers' and patients' experiences of HR care to develop an intervention to operationalize HR care in HIV primary care settings. A preliminary exploration of the feasibility, acceptability, and appropriateness of the newly developed intervention will be conducted with HIV providers. Ultimately this research trajectory aims to improve adherence to care and health outcomes for PLWH who use drugs.

Public health relevance
People living with HIV (PLWH) who use drugs experience poor health outcomes including lower rates of retention in HIV care and higher rates of unsuppressed viral load, resulting in secondary infections and increased mortality. The proposed study will used mixed methods to explore (a) providers’ attitudes towards working with PLWH who use drugs as well as their preparedness for delivering harm reduction care; (b) patients’ experiences of stigma in healthcare settings, viewed from a multi-level lens and (c) the extent to which HR strategies and relational harm reduction buffer the effects of stigma in HIV primary care settings, contributing to improved clinical outcomes. The study will also use these findings to inform the development of an intervention to operationalize harm reduction in healthcare settings, using stakeholder-engaged and human-centered design approaches, presenting a novel path to improving outcomes for PLWH who use drugs.